Identification and characterization of clonal expansions in aging and aging-related disease

Project Summary
Clonal expansions increase with age throughout many tissues in the body. These outgrowths are driven by
somatic mutations that provide a selective advantage over wild-type cells within a specific microenvironment.
Clonal expansions radically increase with age, and are also shaped by disease-related factors. How these factors
and clonal mosaicism (CM), reciprocally influences each other constitute some of the most important biological
questions in current human genetics. A detailed understanding of the biology of aging at the cellular and
molecular level is needed for the development of potential mitigation therapies that target aging morbidities.
To make progress toward this goal, we need enhanced ability to identify and characterize recurrent somatic
mutations in both healthy and diseased aging tissues at high-resolution. As identification of clones is hampered
by low tissue availability and resource-intensive DNA sequencing methods, conceptual and technical innovation
overcoming these challenges could rapidly accelerate the pace of variant discovery. Once discovered, functional
characterization of these clonal variants in genetically heterogenous tissues requires application of genotype-
aware, multi-modality methods in primary human samples to link genotypes and epigenetic profiles of individual
cells. Currently, no such tools exist to characterize multiple molecular features of the somatic epigenome.
To address these important gaps, we aim to (i) develop tools for the identification of candidate somatic variants
at scale from publicly available data and (ii) apply novel technologies that map genotype to epigenetic phenotype
in single cells, enabling analysis of multiple tissues from clinical samples obtained from aging individuals.
Specifically, we aim to harness advancements in machine learning to develop a tool that can accurately identify
somatic variants in bulk RNA-seq and apply it to publicly available data in healthy and diseased tissue from aged
individuals. We believe that we can gain valuable information about the clonal architecture of diabetes, obesity,
hypertension and other age-related diseases from our public databases at low cost and high speed.
Furthermore, we aim to examine how epigenetic modifier mutations shape the chromatin regulatory landscape
(including histone modifications and chromatin accessibility) to promote clonal outgrowth in CM. We will use
newly developed tools to assay genotype, chromatin accessibility and histone marks in ASXL1-mutant CH and
FOXO1-mutant fatty liver disease to define differentially accessible and active regions, their associated genes
and transcription factor binding motifs and their enrichment along lineage trajectories. By integrating these
modalities, we will have an unprecedented view of the effect of somatic variants on the aging epigenome and
gain insights into how these mutations may drive clonal expansion. This project will be ideal for a training
physician-scientist, given its use of novel sequencing technologies and direct clinical implications. With the
mentorship of my sponsor, thesis committee, MD- PhD program, and the support of this fellowship, I am confident
I will be well prepared to pursue and achieve my goal of being a physician scientist and independent investigator.

Public health relevance
Project Narrative Clonal expansions driven by somatic mutations arise almost ubiquitously throughout both healthy and diseased human tissues as we age. Some of these clones have been linked to chronic disease and other aging associated maladies, however, what drives clonal expansions and how they affect tissue integrity and function are not well defined. This project aims to develop and apply novel methods for the discovery of somatic mutations driving expansion in human tissue and multi -omic single-cell mapping of these driver mutation genotypes to molecular phenotypes.